HBV replication and carcinogenesis

DESCRIPTION (provided by applicant): Hepatitis B virus (HBV) is a hepatotropic virus that can cause severe liver diseases including acute and chronic hepatitis, liver cirrhosis and hepatocellular carcinoma (HCC). There are 350-400 million people in the world chronically infected by this virus, resulting in an estimated 1 million deaths every year. In the U.S., the chronic HBV carrier population is about 1.2 million and in China, the carrier population is about 100 million. Recently, we discovered that HBV could induce autophagy to enhance its DNA replication. We also found that impairing autophagy could induce the initiation but impede the progression of hepatocarcinogenesis in a mouse model. These previous studies of ours demonstrated an important role of autophagy in HBV replication and carcinogenesis. Our proposed research is to continue these novel findings to further study the interplay between HBV and its host. Specifically, we will study the molecular mechanism of HBV-induced autophagy. Our recent studies indicated that the HBV X protein could bind to the class III phosphatidylinositol-3-kinase (PI3KC3) to enhance its enzymatic activity. For that reason, we will further determine how this interaction between HBx and PI3KC3 induces autophagy. We will also investigate how autophagy enhances HBV DNA replication. We will determine whether autophagic vacuoles serve as the platform for HBV DNA replication and whether autophagy affects cellular factors that regulate HBV DNA replication. Finally, we will determine the role of autophagy in HBV-induced hepatocarcinogenesis. We will examine why impairing autophagy facilitates the initiation of hepatocarcinogenesis and yet in the mean time inhibits its progression. Our attention will be focused on the phenotypic difference of liver tumors produced in the absence and presence of autophagy, the role of tumor suppressors in hepatocarcinogenesis, and the effect of autophagy on hepatic tumor-initiating stem cells. Our proposed research will generate important information for us to understand the interaction between HBV and its host cell and lead to a better understanding of HBV replication and carcinogenesis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Hepatitis B virus (HBV) is an important human pathogen. There are approximately 1.2 million people in the U.S. that are chronically infected by this virus. Many of these patients will develop severe liver diseases including liver cirrhosis and liver cancer and will require liver transplantation for survival. The goal of our proposed research is to understand the interaction between HBV and hepatocytes and how that interaction affects HBV replication and the progression of liver diseases. Our research will improve our knowledge about this important pathogen and lead to the improvements of treatments for HBV patients. __SpecificAimsTextDelimiter__ RESEARCH PLAN (HBV Replication and Carcinogenesis) SPECIFIC AIMS Hepatitis B virus (HBV) is a hepatotropic virus that can cause severe liver diseases including hepatocellular carcinoma (HCC). There are 350-400 million people in the world chronically infected by this virus, resulting in an estimated 1 million deaths every year. In the U.S., the chronic HBV carrier population is about 1.2 million and in China, it is about 100 million. Recently, we discovered that HBV could induce autophagy in cell cultures, in the liver of transgenic mice that carry an over-length HBV genome, and during natural infection. We also found that autophagy could enhance HBV DNA replication. More recently, we also discovered that autophagy played both positive and negative roles in HBV-induced hepatocarcinogenesis. We found that impairing autophagy could greatly facilitate the initiation of hepatocarcinogenesis both in the presence or absence of HBV and suppress hepatocellular proliferation. These previous studies of ours demonstrated an important role of autophagy in HBV replication and carcinogenesis. During this grant period, we will continue these novel findings to further investigate the role of autophagy in the HBV life cycle and hepatocarcinogenesis. Specifically, we will study: Aim 1. Mechanism of HBV-induced autophagy Our recent studies indicated that the induction of autophagy by HBV was mediated by its X protein (HBx), which binds to the class III phosphatidylinositol-3-kinase (PI3KC3) to enhance its enzymatic activity. In this aim, we will further determine how HBx interacts with PI3KC3, which is a multiple subunit complex, to induce autophagy. Aim 2. Mechanism of autophagy in HBV DNA replication Our recent studies indicated that the inhibition of autophagy would suppress HBV DNA replication both in cell cultures and in transgenic mice that carry an over-length HBV genome. In this aim, we will determine whether autophagic vacuoles serve as the platform for HBV DNA replication and whether autophagy affects cellular factors that regulate HBV DNA replication. Aim 3. Mechanism of autophagy in HBV-induced hepatocarcinogenesis Atg5 is a protein factor critical for autophagy. Our preliminary studies indicated that impairing autophagy in the liver by abolishing the expression of Atg5 would induce liver tumors in 100% of mice by 10 months of age, indicating an important role of autophagy in suppressing the initiation of hepatocarcinogenesis. Interestingly, histological analysis of the tumors in HBV transgenic mice with the liver-specific knockout of Atg5 revealed hepatic focal hyperplasia and adenomas without visible HCC. As HBV could induce spontaneous HCC in mice without the Atg5-knockout, this observation also suggested an important role of autophagy in the progression of HCC. Our further studies indicated that the liver-specific knockout of Atg5 could suppress hepatocellular proliferation. The goal this aim is to continue to use hepatoma cells and HBV transgenic mice as a model to study the role of autophagy in the initiation and progression of hepatocarcinogenesis.